Effects of mild traumatic brain injury in a mouse model of cerebral amyloid angiopathy

Traumatic brain injury (TBI) is a condition in which normal brain function is impaired by an external force. TBI is
estimated to affect ~69 million people worldwide each year. Mild TBI’s are the most common form of brain injury
(~70-90% of all cases), characterized by little-to-no time unconscious and minimal observable deficits
immediately post-injury. Mild brain injuries are commonly attributed to participation in contact sports (e.g. boxing,
football, soccer, hockey), military service, and as a result of intimate partner violence. Even mild TBI, especially
following repeated injuries, has devastating acute and long-term consequences, including an increased risk of
stroke and dementia. Given the clear evidence that TBI increases the risk of dementia in later life, it is of great
interest to determine the mechanisms that drive the relationship between different types of TBIs and various
dementia-associated neuropathologies, so that targets for intervention may be identified. Repetitive mild TBI has
been most notably associated with chronic traumatic encephalopathy (a tauopathy), though some evidence
suggests it may also contribute to Alzheimer’s and other neurodegenerative conditions. However, less is known
about whether cerebral amyloid angiopathy (CAA) may also be a mechanism linking TBI to dementia. CAA is
the accumulation of amyloid protein (most commonly beta-amyloid, associated with Alzheimer's disease) within
the cerebral vasculature, contributing to increased risk of dementia [both vascular contributions to cognitive
impairment and dementia (VCID) and Alzheimer's disease], as well as ischemic and hemorrhagic stroke.
Increased levels of CAA are observed in former athletes, who tend to have a history of repetitive mild brain
injuries. Experimental designs using animal models are needed to determine whether and how repetitive mild
TBI influences the initiation and progression of CAA and related pathology. Here, we will subject Tg-SwDI mice
(a transgenic mouse model of CAA) to repetitive mild TBI (1x/day for 5 consecutive days) starting at ~2 months
of age. This age is roughly equivalent to late adolescence/young adulthood, when TBI is most common, and is
prior to the onset of significant CAA pathology and cognitive impairment in this strain. We will then determine
whether cognitive-behavioral deficits and neuropathology are altered at two time-points post-TBI (short-term: 7
days and longer-term: 3 months). Additionally, we will investigate whether biological sex moderates the
relationship between repetitive mild TBI and CAA-associated outcomes. Our long-term goal is to identify
mechanisms linking TBI and increased dementia risk, which may in turn reveal novel targets for treatment.

Public health relevance
There is evidence to suggest that traumatic brain injury (TBI) increases the risk of dementia and stroke; however, pathological mechanisms linking these conditions are yet to be fully elucidated. Cerebral amyloid angiopathy (CAA), the accumulation of amyloid protein (most commonly beta-amyloid, associated with Alzheimer's disease) within cerebral vasculature, may be one such mechanism. Following a repetitive mild TBI protocol starting at 2 months of age, we will determine whether cognitive deficits and neuropathology are altered at several timepoints post-TBI (short term: 7 days, and longer-term: 3 months) in a mouse model of CAA, with the goal of identifying mechanisms linking these conditions, which may in turn reveal novel targets for treatment.